Exposome Monitoring for Skin Diseases through Liquid Biopsy Multiomics

Project Summary
Psoriasis and atopic dermatitis are common, immune-mediated skin diseases that are significantly influenced
by environmental factors. Developing remote monitoring technologies capable of capturing these
environmental factors and their effect on skin disease would advance exposome research. In this study, we
use non-invasive biosample collection methods and bioinformatic and machine learning approaches to monitor
changes in the skin of patients with psoriasis and atopic dermatitis. This study will advance our knowledge of
the cutaneous immunobiology of inflammatory skin disease and provide new paradigms for remote, home-
based research.

Public health relevance
Project Narrative Psoriasis and atopic dermatitis are chronic inflammatory skin diseases that are influenced by environmental exposures. There is a need to develop better approaches monitor the human exposome remotely. In this diversity supplement proposal, we use a novel non-invasive liquid biopsy approach and cutting-edge bioinformatics methods to identify dysregulated pathways and biomarkers in psoriasis and atopic dermatitis.